Effects of macrophage-derived exosomes on dorsal root ganglion neurons in models of systemic pain

PROJECT SUMMARY
Chronic pain is a serious condition which is produced and maintained by a variety of different
mechanisms, many of which remain poorly understood This has led to difficulties in providing effective
treatments. One key mechanism underlying chronic pain conditions, such as nociplastic pain, is central
sensitization in which plastic changes at the level of the spinal cord contribute to and maintain hypernociception.
To add further complexity, we have found that different mechanisms underlie the acute, transition, and chronic
phases of central sensitization in our model of nociplastic pain. In order to better understand, and therefore
successfully treat, chronic pain conditions, the mechanisms underlying these three phases, as well as resolution
of chronic pain, must be elucidated. Already, I have shown that excitation of capsaicin-sensitive afferents
attenuates the response of sGABAn to low-intensity synaptic stimulation. Furthermore, I have shown that spinal
microglia and inflammation mediate the chronic phase of central sensitization underlying a nociplastic pain state.
In the F99 phase of the proposed project, I will further characterize the neuronal circuitry underlying the
acute and maintenance phases of central sensitization, focusing on 1) how nociceptor activation and subsequent
release of reactive oxygen species impair Aβ-fiber-evoked sGABAn activation in the acute phase, 2) whether
such impairment allows low-threshold afferent inputs to activate spinal microglia to drive the transition phase,
and 3) if reactive microglia and inflammatory mediators maintain the impairment in the chronic phase.
In the K00 phase, I will move to a prominent pain research laboratory to investigate the mechanisms by
which pro-resolution lipid mediators, such as resolvins, are dysregulated in pain conditions, and their effect on
nociceptive circuitry. Additionally, I will investigate how resolvins and the circuitry which they effect may be
manipulated to convert chronic pain back to resolving pain.
Overall, the proposed project will provide key understanding of the chronification and resolution of
nociceptive neural circuit sensitization. These will ultimately reveal new therapeutic targets, allowing for the
development of better pain treatments.

Public health relevance
PROJECT NARRATIVE Chronic pain conditions affect a large portion of the population and are often refractory to treatment, largely due to gaps in current understanding of the underlying sexually dimorphic mechanisms producing, maintaining, and resolving chronic pain. Utilizing a novel animal model of pain chronification, this project seeks to elucidate male-specific mechanisms underlying the unique plastic changes occurring in each of these phases of pain chronification. In doing so, new targets for the prevention and treatment of chronic pain conditions will be identified.